PROGRAF (TACROLIMUS) VS CYCLOSPORINE CONTINUATION IN CHRONIC RENAL ALLOGRAFT FAIL

The objective of this study is to compare the incidence, progression and severity of chronic renal allograft failure in at risk patients who are converted from cyclosporine-based to tacrolimus-based immunosupression to patients who remain on cyclosporine-based therapy.